Autonomous diagnosis and management of the critically ill during air transport (ADMIT)

Project Summary/Abstract: Cardiorespiratory instability (CRI) is common in trauma patients and other
acutely ill patients being transferred from trauma sites or between hospital centers. Although
paramedics/nurses (PM/RN) have some success in rescuing unstable patients with CRI using defined
protocols and decrease incidence of inter-transport severe circulatory shock, the shock recognition tools
available and resuscitation endpoints are limited to blood pressure and heart rate thresholds. However, CRI is
often unrecognized until it is well established when patients are more refractory to treatment, or progressed to
organ injury. If one could accurately predict who, when and why these critically ill patients develop CRI, then
effective preemptive treatments could be given to improve care and triage resulting in better use of healthcare
resources. We have shown that an integrated monitoring system alert obtained from continuous noninvasively
acquired monitoring parameters coupled to a care algorithm improved step-down unit (SDU) patient outcomes.
We also applied machine learning (ML) modeling to our clinically-relevant porcine model of hemorrhagic shock
to characterize responses to hypovolemia, hemorrhage, and resuscitation, predict which animals would or
would not collapse during hypovolemia, and identify occult bleeding 5 minutes earlier than with traditional
monitoring. We now propose to apply our work to vulnerable STAT MedEvac air transported patients. We will
validate these approaches in our existing >5,000 patient STAT MedEvac database, containing highly granular
continuous non-invasive monitoring waveforms of air transported critically ill patients linked to their primary
care and inpatient electronic health records (EHR). This level of patient information and granularity linked to
treatment data and patient outcomes is unprecedented. We will extend our analysis to include more complex
CRI, richer data, deeper analytics, and larger libraries of critically ill patients while in air transport, linking our
proven Functional Hemodynamic Monitoring (FHM) principles for pathophysiologic diagnosis and resuscitation
with non-invasive monitoring to operationalize personalized resuscitation. We will concurrently running two
specific aims. First, we will develop through the Carnegie Melon University Auton Lab multivariable models
through ML data-driven classification techniques to predict CRI. We will do this initially on our existing porcine
hemorrhagic shock model data (n=60) and then on our STAT MedEvac dataset linked to EHR (n >5,000
patients), determining the minimal data (measures, sampling frequency, observation duration) required to
robustly identify deviation from health, likely CRI cause, and response to treatment (endpoint of resuscitation),
as well as the incremental benefit of additional variables, analysis, lead-time and sampling frequency to predict
CRI and response to treatment, and examine the trade-offs between model parsimony and specificity. Second,
we will evaluate our existing clinical decision support (CDS) tools to interface with FHM principles and ML-
defined interactions, and trial this in silico first on our porcine hemorrhagic shock resuscitation, then on our
STAT MedEvac data, followed by prospective human simulation on flight crew PM/RN (n=160) during annual
training for agreement and benefit, defining effectiveness based on diagnosis accuracy, time to diagnosis,
intervention choice accuracy and time to intervention. This iterative process will modify the existing CDS
platform into one more specifically suited for air transport scenarios. Finally, we will evaluate the resultant
semi-autonomous management protocol initially in retrospect in 100 STAT MedEvac patients and 10
Emergency Department trauma patients and then prospectively by active CDS in a final 100 STAT MedEvac
patients. We will prospectively analyze the effectiveness of these calibrated CDS tools for predictive ability of
the various ML models and apply the best, most practical and parsimonious predictive models for clinical care
during transport based on patient population, pathological processes and support staff.

Public health relevance
Project narrative We propose to develop and trial of proactive approach to diagnosis and management of vulnerable critically ill patients during STAT MedEvac air transport from trauma sites and inter-hospital transfer. We will use machine learning approaches to plumb our existing rich >5500 patient STAT MedEvac waveform data linked to their electronic health records to define level of severity, predict impending cardiovascular instability and to both drive in-flight resuscitation and alert receiving Emergency Department triage. We will use our existing clinically relevant porcine model of hemorrhagic shock to focus initial human instability algorithms and then refine our existing graph user interface clinical decisions support (CDS) algorithm, first in animal and with paramedic/nurse dyads in human simulation and then during actual STAT MedEvac air transport and Emergency Department care of trauma patients creating a scalable CDS platform to support paramedic/nurse smart monitoring and proactive resuscitation of these high risk patients.